The Impact of hiPSC-Derived Microglia in Human Brain Development in Health and Disease

Abstract
The main goal of this project is to determine the contribution of human microglia in the establishment of
early neural networks during development in healthy and autistic conditions. Although the exact cause of
Autism Spectrum Disorders (ASD) remains unclear, epigenetic, genetic and environmental factors are at play.
Given that ASD is a complex multifactorial disorder and that epigenetic modifications have been shown to
control microglial phenotypes/plasticity, we hypothesized that microglial epigenetic signature might influence
neuronal development. Given that microglia originate in the periphery and later invade the brain, they are most
likely the first brain cell type to be exposed to an environmental factor or at least be impacted by the
environmental factor given their role as gate keepers of the brain. Therefore, a better understanding of the
genetic, environmental or a synergistic impact of both, will pave the way to a better understanding of human
neurodevelopment and human microglial roles during this process yielding to the discovery of novel
therapeutic targets and efficient therapies for a broad range of neurological disorders including ASD. Thus,
with this project, we aim to establish whether and how human microglia interfere with neural network
establishment and if high-risk ASD epigenetic genes could alter their function and their role during human
neurodevelopment. Based on our preliminary data we propose the following specific aims are: Aim 1:
Determine the role of healthy human microglia on healthy brain cortical organoids (BCO), Aim 2:
Measure the impact of microglia carrying ASD mutations on BCO development and function, and Aim
3: Impact of environmental ASD-risk factors in combination with underlying genetic predisposition: the
two-hit hypothesis. Here we will test the isolated and additive effect of ASD-related environmental factors on
the function of microglia and its impact on BCO physiology.

Public health relevance
PROJECT NARATIVE The main goal of this project is to determine the contribution of human microglia in the establishment of early neural networks during development in healthy and autistic conditions. We will use a human experimental brain organoid model to determine the impact of microglia carrying ASD-related mutations and exposed to environmental risk factors in gene expression, cell populations and network formation.